Morphologic and Kinematic Adaptations of the Subtalar Joint after Ankle Fusion Surgery in Patients with Varus-type Ankle Osteoarthritis

PROJECT SUMMARY
Tibiotalar arthrodesis, or ‘ankle fusion’, is the gold standard surgical treatment for posttraumatic ankle
osteoarthritis (OA). Ankle fusion brings pain relief, at least in the short term; however, elimination of motion at
the tibiotalar joint imposes new demands at the subtalar joint, which may exceed the limit of cartilage and result
in secondary OA. Most patients undergoing ankle fusion surgery have preoperative deformities in the alignment
of the tibiotalar and subtalar joints. Notably, 60% of all patients with ankle OA have varus malalignment of the
tibiotalar joint. Recently, it was discovered that the ipsilateral subtalar joint adopts ‘compensatory’ valgus
alignment in approximately half of those patients with varus-type ankle OA. Opposing varus-valgus deformities
tend to neutralize the overall alignment of the leg and hindfoot, making it appear normal on gross clinical
inspection. Unfortunately, while current surgical recommendations for ankle fusion provide clear guidance for
how to correct varus malalignment of the tibiotalar joint, they make no stipulation for compensatory valgus
alignment of subtalar joint. Results from our recently completed R21 project illustrate the potential for surgeons
to strategically align the ankle fusion to control for postoperative motion, joint space distance, and congruency
of the subtalar joint, which could in turn mediate secondary OA. Still, the specific effects of ankle fusion surgery
on the form and function of the subtalar joint have not been evaluated longitudinally in-vivo. Our broad goal is to
identify mechanical and structural factors that lead to inferior patient outcomes after ankle fusion. The R01
proposed herein addresses this goal through quantitative, longitudinal characterization of the effects of ankle
fusion surgery on the form and function of the subtalar joint in-vivo. Here, we take a focused, mechanistic look
at patients with varus ankle OA that are subdivided into two equal groups (with and without compensatory valgus
alignment of the subtalar joint; n = 24 per group). Guided by our preliminary data, we hypothesize that patients
with preoperative compensatory alignment of the subtalar joint are at greater risk of experiencing altered form-
function relationships and inferior outcomes at 24 months post ankle fusion surgery. Aim 1 will quantify how
ankle fusion changes the alignment and morphology of the subtalar joint from longitudinal statistical shape
models constructed from weight-bearing computed tomography scans. Aim 2 will quantify how ankle fusion
changes the in vivo kinematics of the subtalar joint during walking, stair ascent, and stair descent using dual
fluoroscopy. Aim 3 will synthesize these data to identify and isolate the role preoperative alignment of the subtalar
joint has on subtalar joint morphology, in vivo motion, and patient outcomes. If successful, this project will provide
the first and only mechanistic understanding of the effects of ankle fusion. We anticipate that completion of these
aims will also provide prerequisite information for us to pursue a future interventional study, where we would
evaluate whether accounting for valgus compensation at the time of surgery yields better outcomes.

Public health relevance
PROJECT NARRATIVE The results of this research will provide quantitative characterization of anatomical form and its relationship with function in patients that undergo ankle fusion surgery to treat ankle osteoarthritis. These data should help surgeons to better address deformities at the time of ankle fusion surgery, which could in turn improve clinical outcomes and reduce the likelihood that patients will develop secondary subtalar arthritis later in life.